Motor Cortex Stimulation Reverses Maladaptive Plasticity Following Spinal Injury

DESCRIPTION (provided by applicant): Following spinal cord injury, a majority of patients develop maladaptive plastic changes within the central nervous system (CNS). These changes result in abnormal regulation of peripheral inputs, and impaired perception of tactile and painful stimuli. The majority of these patients suffer because conventional treatments fail to reverse these maladaptive changes. An alternative and potentially effective modality of treatment-motor cortex stimulation (MCS)-offers hope for these patients. However, treatment outcomes with MCS are variable mainly because of the lack of understanding of how stimulation of the motor cortex reverses these maladaptive changes in the CNS. The goal of this application is to elucidate the neurobiological basis of regained sensory processing in the CNS following MCS. To this end, we use a rodent model of spinal cord injury. We demonstrated recently that activity in the GABAergic nucleus zona incerta (ZI) is suppressed in animals following spinal cord injury, resulting in enhanced activity in the posterior thalamus (PO) and enhanced flow of peripheral inputs to the neocortex. We also demonstrate that electrical stimulation of ZI mimics the effects of MCS and reverses maladaptive plastic changes observed following spinal cord injury. Based on these findings, and because the motor cortex projects densely upon ZI, we propose that MCS produces pain relief by enhancing inhibitory inputs to the posterior thalamus from zona incerta and that chronic MCS results in long term synaptic changes in the incerto-thalamic circuit. We will test the following aims: Aim 1: MCS suppresses hyperalgesia by enhancing inhibitory inputs from ZI to PO. Aim 2: Reduction of hyperalgesia is causally related to the activation of the incerto-thalamic pathway. Aim 3: MCS produces long lasting changes in the incerto-thalamic circuitry.

Public health relevance
PUBLIC HEALTH RELEVANCE: One of the most debilitating consequences of spinal cord injury is the development of chronic intractable neuropathic pain (central pain syndrome). The pain is severe and relentless and current treatment methods offer no hope. Motor cortex stimulation (MCS) was introduced-almost 20 years ago-as a modality for the treatment of central pain syndrome when all other treatments have failed. However, the outcome of the treatment is variable. A major impediment to implementing MCS in the clinical setting and improving the success rate is the fact that the mechanisms by which MCS affects pain processing are unknown. Here, we take advantage of an animal model of central pain produced by spinal cord injury to study the mechanisms by which MCS affects the activity of specific neuronal circuits. Narrative One of the most debilitating consequences of spinal cord injury is the development of chronic intractable neuropathic pain (central pain syndrome). The pain is sever and relentless and current treatment methods offer no hope. Motor cortex stimulation (MCS) was introduced-almost 20 years ago-as a modality for the treatment of central pain syndrome when all other treatments have failed. However, the outcome of the treatment is variable. A major impediment to implementing MCS in the clinical setting and improving the success rate is the fact that the mechanisms by which MCS affects pain processing are unknown. Here, we take advantage of an animal model of central pain produced by spinal cord injury to study the mechanisms by which MCS affects the activity of specific neuronal circuits. __SpecificAimsTextDelimiter__ Specific Aims Following spinal cord injury or a cerebrovascular accident (stroke), a majority of patients develop excruciating and intractable pain for which conventional pharmacological treatment is not effective. An alternative and effective modality of treatment-motor cortex stimulation (MCS)-offers hope for these patients. However, treatment procedures vary widely among clinicians, and outcomes with MCS are inconsistent. This is mainly due to a lack of understanding of how MCS achieves pain relief. To address this question, we adapted an animal model of spinal cord injury that recapitulates the clinical characteristics of central pain syndrome (CPS), and in which MCS alleviates pain. In a series of recent studies we demonstrated that the inhibitory nucleus zona incerta (ZI) regulates the flow of nociceptive and somatosensory information through the posterior thalamus (PO), and that maladaptive plasticity in ZI is associated with the development of CPS. We discovered that inhibitory inputs from ZI to PO are suppressed in animals with CPS, resulting in an abnormally enhanced activity in PO neurons, and in neurons in the primary somatosensory cortex (S1) that receive inputs from PO. The enhanced activity in PO correlates with nociceptive behavioral metrics obtained from the same animals. We also observed that electrical stimulation of ZI ameliorates mechanical hyperalgesia in animals with CPS by restoring the inhibitory drive, thus establishing a causal relationship between changes in ZI and the pathophysiology of CPS. We are now poised to take advantage of this CPS model inhibitory inputs that project to PO. In a series of exciting preliminary studies, we implanted stimulating electrodes over the primary motor cortex (M1) of CPS rats. We found that MCS reduces hyperalgesia in these animals, and that the reduction in hyperalgesia persists long after the stimulation ended. Hyperalgesia was reduced in a manner consistent with that observed after ZI stimulation. Because M1 projects heavily upon ZI, we reasoned that MCS reduces hyperalgesia by enhancing activity in ZI which in turn will suppress activity in PO. In agreement with this, we found that reversible inactivation of ZI or PO in behaving animals blocked the analgesic effects of MCS. These findings suggest that ZI plays a key role in mediating the effects observed after MCS. Based on these findings we propose that MCS produces pain relief by enhancing inhibitory inputs to the posterior thalamus from zona incerta and that chronic MCS results in long term synaptic changes in the incerto-thalamic circuit. Aim 1. Hypothesis: MCS suppresses hyperalgesia by enhancing inhibitory inputs from ZI to PO. We will perform in vivo electrophysiological recordings in anesthetized and un-anesthetized rats to compare the time course of MCS effects on pain perception and on neuronal activity in the incerto-thalamic system. We predict: (1) MCS enhances the activity of ZI neurons that project to PO. (2) MCS suppresses evoked and spontaneous activity of PO neurons. (3) The long lasting reduction in hyperalgesia after MCS correlates with suppressed activity in PO neurons. Aim 2. Hypothesis: Reduction of hyperalgesia is causally related to the activation of the incerto-thalamic pathway. In anesthetized animals we predict: (1) Pharmacologic inactivation of ZI blocks the effects of MCS on spontaneous and evoked activity of PO neurons. (2) Pharmacologic inactivation of ZI blocks the behavioral effects of MCS. (3) Pharmacologic inactivation of PO alleviates hyperalgesia. Aim 3. Hypothesis: MCS produces long lasting changes in the incerto-thalamic circuitry. In this aim, we use in vivo and in vitro electrophysiological recordings to test the following predictions. (1) MCS enhances suprathreshold responses of ZI neurons to orthodromic stimulation of M1. (2) MCS enhances the efficacy of M1->ZI synapses. (3) MCS enhances the efficacy of ZI->PO synapses. and our exciting findings to elucidate the mechanisms by which MCS ameliorates chronic neuropathic pain. Our overarching hypothesis is that MCS ameliorated pain by activating S1 Normal CPS MCS M1 S1 M1 S1 M1 PO PO ZI ZI ZI PO Spinal cord Spinal cord Spinal cord Schematic of our overarching hypothesis: In normal conditions, nociceptive transmission through PO is regulated by powerful inhibition from ZI. In CPS, ZI activity is suppressed and activity in PO is enhanced. MCS enhances activity of ZI and restores inhibition in the thalamus and spinal cord. [Blue represents inhibitory inputs; Excitatory Inputs; line thickness represents connection red: strength].